Role of Metallothionein 1 E in the Protection of Cystic Fibrosis-Related Diabetes

PROJECT SUMMARY/ABSTRACT
Cystic fibrosis (CF) is the fifth leading cause of death in the US. As a life-shortening genetic disease, CF is
characterized by abnormalities in the pulmonary and digestive systems due to systemic inflammation, fibrosis,
and tissue degradation. About half of adult CF patients experience cystic fibrosis related diabetes (CFRD). Unlike
the common type I or type II diabetes, CFRD develops at the very early stages of life of people with CF and
leads to greatly worsened lung disease. Although new therapeutics – such as the triple combination CFTR
modulator therapy TRIKAFTA – are impacting lung function for many patients, these therapies do not appear to
be solving the endocrine problems experienced by people with CF. More precise and effective methods of early
detection of this disease are urgently needed for progression prevention and to drastically lower the death rate.
This project, if successful, will transform the management of patients with CFRD into more effective treatment
strategies. Our first goal is to understand the role of MT1E on β-cell functions and survival during the
development of CFRD. Our second goal is to elucidate the impact of exocrine cells expressing mutant CFTR
on endocrine islets. Our third goal is to resolve a single-cell (scRNA-seq) map of islets from healthy, CFRD,
and TRIKAFTA-treated CF ferrets. Our central hypothesis is that redox imbalance and tissue remodeling
contribute to CFRD progression by altering endocrine function through the metallothionein 1 E pathway. First,
this project is expected to shed light on the molecular mechanism of Metallothionein 1E (MT1E) in regulating
pancreatic damage in patients with CFRD, using pluripotent stem cell-derived human pancreatic exocrine and
endocrine organoids. Second, by using cutting-edge collagen-based magnetic resonance imaging, this project
will map the location and severity of fibrosis in the pancreas during the development of CFRD. Finally, performing
high throughput single-cell RNA sequencing analysis of the pre-clinical model of CFRD, the CFTRG551D/-KI ferret,
this project will identify essential biomarkers during the progression of CFRD. Ultimately, these studies broaden
our understanding of the pathogenesis of CFRD and provide the basis for using Magnetic resonance imaging
(MRI) as a potential diagnostic approach for disease early detection. The project also serves as an opportunity
for the PI to shift directions in his research program, learning new techniques that will greatly enable his future
career.

Public health relevance
Project Narrative Cystic Fibrosis (CF) is the most common lethal genetic disease in US Caucasians, arising from mutations in the gene encoding CF transmembrane conductance regulator (CFTR). CF-related diabetes (CFRD), the most prevalent co-morbidity, develops at the early age of childhood. The proposal will help to understand the pathogenesis in the pancreas during the development of CFRD, and to provide all people with CF the opportunity to lead long, fulfilling lives.